PATHway for Biomedical Careers Program

PATHway for Biomedical Careers Summary
The Administrative Core oversees the PATHway to Biomedical Careers program and supports the introduction
and development of undergraduate research projects at the primarily undergraduate institution (PUI) and
community college (CC) partners, provide opportunities for student research experiences (SRE) throughout the
network, and support of a state-of-the-art Data Sciences core to provide cutting-edge services to our INBRE
students and investigators at all stages of development.
Please see the ADMIN CORE summary for more details of the PATHway program.